Testing a culturally tailored behavioral intervention to reduce co-occurring substance use and HIV risk among stimulant-using Latinx Man who have sex with Man in South Florida.

Project Summary/Abstract
Career Goal. My long-term career goals are: (1) to obtain and secure a full-time tenure track appointment; and
(2) to become an independently funded community-engaged Latinx public health scientist to address immigrant
health as well as substance use/HIV risk in Latinx populations. This research and training grant will provide me
with the opportunity to fortify my research skills as a postdoctoral fellow at FIU to successfully transition to a
prevention intervention scientist that addresses prominent health inequalities faced by stimulant-using LMSM.
Career Development. This K99/R00 research and training plan will catalyze my efforts to acquire the advanced
training necessary to develop and test culturally informed behavioral interventions addressing the intersection of
stimulant use and HIV risk in LMSM. During the K99 phase, my training goals consist of (1) developing advanced
competencies in designing culturally informed evidence-based interventions;(2) pursuing advanced training in
Randomize Control Trial methods necessary to examine the feasibility, acceptability, and preliminary efficacy of
a culturally informed behavioral intervention and (3) acquire knowledge in the application of SNA methods to
assess the effects of a culturally informed behavioral intervention on participant's social network composition.
Research Project. Latinx communities are the fastest-growing group in the US.24 LMSM (foreign and US-born)
are disproportionately affected by HIV and other sexually transmitted diseases. The K99/R00 proposal will focus
on this underserved population of stimulant-using LMSM who are in desperate need of culturally informed
interventions to mitigate co-occurring stimulant use and HIV risk in the era of PrEP. Developing a behavioral
intervention that addresses cultural factors and social networks as key determinants of stimulant use and HIV
risk in LMSM represents a viable strategy to reduce stimulant use, decrease engagement in condomless anal
sex (CAS), and support PrEP uptake in LMSM. Specific Aims. (1) Conduct formative research through mixed
methods to develop a culturally informed intervention targeting co-occurring stimulant use and HIV risk in LMSM
who are not on PrEP and (2) Conduct a pilot Randomize Control Trial to test the feasibility, acceptability and
preliminary efficacy of a culturally informed intervention for optimizing PrEP uptake as the primary outcome with
60 stimulant-using LMSM. Mentorship Team: My efforts will be guided by an accomplished, interdisciplinary
team of mentors committed to support my transition to an independent investigator.

Public health relevance
Project Narrative Latinx men who have sex with men (LMSM) account for the majority of new HIV infections in South Florida and are one of the only populations in the US where HIV incidence is increasing. Expanded efforts are needed to optimize the benefits of PrEP in stimulant-using LMSM, especially approaches that address the role of key cultural factors (e.g., acculturation) and social networks in relation to stimulant use/HIV risk. The proposed formative clinical research aims to develop and pilot test a culturally tailored intervention targeting the intersection of substance use and HIV in Latinx men who have sex with men (LMSM).